General collaborations

Our overall goal is to collaborate with epidemiologists on a variety public health studies within NIH and NICHD. This includes assistance on formulating study aims, guidance on study designs, assistance on study instruments development. It also includes collaborations on study participants recruitment, data collection and cleaning, statistical analysis, and study results disseminations. Our overall goal is to collaborate with epidemiologists on a variety public health studies within NIH and NICHD. This includes assistance on formulating study aims, guidance on study designs, assistance on study instruments development. It also includes collaborations on study participants recruitment, data collection and cleaning, statistical analysis, and study results disseminations.